RADIOLOGICAL RESEARCH ACCELERATOR FACILITY: SCIENTIST &STUDENT TRAINING

The specific objective is to train scientists and students in the use intruments available in the Radiological Research Accelerator Facility.